Targeting autophagy to reduce inflammasome-mediated inflammation and immune dysfunction in HIV and methamphetamine use

Project Summary/Abstract
Methamphetamine (MA), a potent addictive psychostimulant, is highly prevalent in HIV-infected
individuals. Even for individuals with suppressive anti-retroviral therapy (ART), MA abuse has been linked to
increased viral load, accelerated disease progression, and higher mortality rates in people living with HIV
(PLWH). Despite well-documented evidence of MA's adverse effects on the central nervous system (CNS) and
cognitive function, its effects on immunity remain unclear. Further research is needed to determine the
molecular mechanisms of MA on the immune system, which could lead to targeted therapeutic interventions.
Previous reports and our studies showed that MA could impair mitochondria function and exacerbate
inflammasome activation and chronic inflammation during HIV infection. Autophagy, a homeostatic cellular
mechanism involved in disposal of damaged organelles and intracellularly pathogens, has been reported to
negatively regulate inflammasome activation. Our recent studies indicate that autophagy inducers such as
rapamycin can induce autophagy, improve mitochondria function, reduce inflammasome activation and chronic
inflammation in HIV infected humanized mice. We also observed improved anti-viral T cell immunity, reduced
viral reservoir and lower viral rebound after ART withdrawal in rapamycin treated mice, suggesting its
therapeutic potentials. In addition, we found that cannabis major components trans-Δ9-tetrahydrocannabinol
(THC) and cannabidiol(CBD) can potently induce autophagy and reduce inflammasome activation in stimulated
macrophages. Therefore, we hypothesize that inducing autophagy through rapamycin or THC/CBD may offer
therapeutic benefits in reducing inflammasome-mediated inflammation in both the periphery and CNS in
individuals with HIV infection and MA use. This, in turn, could enhance anti-viral immunity and decrease viral
reservoirs. We will study the following aims: 1) Determine the effects of methamphetamine on inflammasome
activation and T cell dysfunction during HIV infection with or without ART; 2) Examine the therapeutic potential
of targeting autophagy to reduce excessive inflammasome activation and restore T cell function during HIV
infection and methamphetamine abuse; 3) Investigate the effects of MA and autophagy induction on HIV-
associated CNS inflammation.

Public health relevance
Project Narrative Drug abuse and addiction is inextricably linked with HIV/AIDS pandemic. Among them, methamphetamine abuse has been associated with worse disease outcome and higher mortality rate among people infected with HIV. This study aims to investigate 1) the molecular mechanisms of methamphetamine on inflammation and immune dysfunction in people living with HIV and 2) the therapeutic potentials of autophagy inducers for treating hyperinflammation in HIV infection and methamphetamine abuse.